A Bayesian nonparametric approach to superresolved tracking of multiple molecules inside living cells

Project Summary:
The 2014 Chemistry Nobel Prize was awarded for advances in ﬂuorescent labeling, instrumentation and anal-
ysis methods which together, over the last decade, have resolved particle positions to within ≈20-30 nm.
That is, below the diffraction limit of light used to excite them. Superresolution has subsequently been used
to image β-amyloid ﬁbers tied to neurodegenerative disorders and directly observe diffraction limited protein
clustering linked to cancer phenotypes.
While superresolved localization reveals static cellular structures of immediate relevance to health, it does
not provide direct insight into disease dynamics. Directly observing in vivo dynamics at the single molecule
level demands multi-particle superresolved particle tracking. Superresolved tracking is more difﬁcult than
superresolved localization because – for the same number of photons collected – tracking requires mobile
particles to be localized over multiple image frames. Furthermore, multi-particle superresolved tracking re-
quires that this all be done while accounting for unavoidable overlapping particle trajectories within a conﬁned
cellular volume a few diffraction limited volumes in size. Thus, to date, there is no systematic way to accurately
track more than one protein, of the millions of proteins, inside a volume the size of E. coli’s cytoplasm at once.
The overarching goal is therefore: To provide the ﬁrst principled multi-particle superresolved track-
ing algorithm by exploiting the novel tools of Bayesian nonparametrics (BNPs) that have already deeply
impacted Data Science over the last decade. BNPs can learn particle numbers in each frame and particle
trajectories across all frames in a computationally tractable manner in a way that is directly informed by the
data (photons collected per pixel). The tracking method developed will be applied to multi-particle problems
– such as the assembly/disassembly of serine chemoreceptor, Tsr, complexes on E. coli’s inner membrane
– and problems involving abrupt dynamical changes – such as transitions between bound/unbound states of
RNA polymerases – naturally dealt with in the principled tracking framework proposed.
Two Speciﬁc Aims are proposed. Speciﬁc Aim I – Develop the very ﬁrst, fully-integrated and unsupervised,
superresolved tracking algorithm for multiple diffraction-limited particles under the assumption that particles
diffuse with a single (unknown) diffusion coefﬁcient. Speciﬁc Aim II – Repeat Speciﬁc Aim 1 for the case
where dynamical models according to which particles evolve are unknown or even changing in time (that is,
the restriction that dynamics be governed by simple diffusion is lifted). Within each Aim, we will: determine
particle numbers in each frame by adapting (nonparametric) Bernoulli processes; adapt observation models to
account for complex label photophysics and aliasing artifacts important for fast-moving particle; treat particle
conﬁnement for particle diffusion in small bacterial cells while learning dynamical models by adapting Dirichlet
processes; incorporate detailed camera noise models.

Public health relevance
Project Narrative: Superresolution imaging has provided direct insight into disease mechanisms down to the single molecule level. Here we propose the ﬁrst fully-integrated multi-particle tracking algorithm to go beyond static structures obtained using superresolution and move toward dynamics with single molecule resolution inside living cells.